Histone crotonylation as a novel regulator of learning and memory

PROJECT SUMMARY
The goal of this proposal is to define how novel post-translational modifications (PTMs) on histones are
regulated by neuronal activity and to test their role in learning and memory. In the brain, gene expression
changes facilitate essential neural processes such as memory formation. PTMs like acetylation are known to
regulate these processes. This proposal focuses on crotonylation, a recently discovered histone PTM in the acyl
family. Histone crotonylation impacts gene expression in multiple cell types, generally upregulating expression.
While it is not yet clear whether histone crotonylation also regulates neuronal gene expression and function,
there is evidence showing that it can influence the development of psychological disorders as well as
neurodevelopmental disorders. For instance, several acetyl-lysine readers have a specific preference for
crotonyl-lysine over acetyl-lysine, and mutations in the genes encoding these proteins cause
neurodevelopmental syndromes characterized by developmental delay and intellectual disability. Thus,
understanding the regulation and function of histone crotonylation in the brain has the potential to illuminate
mechanisms by which epigenetic regulators influence disease. To date, the study of crotonylation has been
hindered by a lack of specificity in the reagents that detect crotonylation and by a lack of tools to specifically
manipulate it in physiological contexts. This proposal will leverage novel tools including a crotonyl-specific probe
and crotonyl-specific enzymes to gain an understanding of how histone crotonylation is regulated by neural
activity and to discern how it functions in the regulation of gene expression and in learning and memory.
This proposal presents two integrated aims to test the overarching hypothesis that histone crotonylation
enhances transcription of activity-dependent genes to promote learning and memory formation. In Aim 1, we will
use primary neuronal culture systems to study how neuronal activation affects histone crotonylation over time.
The novel approaches used in this Aim will map the broad, dynamic changes in crotonylation induced by neuronal
activation while also quantifying site-specific histone residues with altered crotonylation status during neuronal
activation. In Aim 2, we will utilize viral vectors to express mutant forms of histone acyl- and deacyl-transferase
enzymes that specifically deposit or remove crotonylation. We will use these enzymes in neuronal cultures to
determine how changes in histone crotonylation affect gene expression in response to activating stimuli. We will
also test whether crotonylation plays a functional role in learning and memory in mice by injecting lentiviruses
expressing crotonyl-specific acyltransferase enzymes under the control of a neuron-specific promoter to increase
or decrease crotonylation. We will then evaluate the effects of these manipulations on memory through
behavioral testing. Ultimately this proposal will define how histone crotonylation is regulated in neurons and how
it functions in transcriptional regulation underlying memory formation in the brain, expanding our understanding
of how epigenetic regulators shape cognitive processes.

Public health relevance
PROJECT NARRATIVE The neuronal transcriptional response to activation enables cognitive processes such as learning and memory. One way that neuronal gene expression can be altered is through the addition or removal of chemical modifiers on histones, proteins that bind and regulate DNA. In this proposal, I will define how crotonylation, a newly identified histone modification, is regulated by neuronal activation, how it influences gene expression during neuronal activation, and how it controls learning and memory.